Molecular and cellular mechanisms of cold allodynia

Project Summary
In the somatosensory system, the detection of external signals, such as mechanical, thermal, and chemical stimuli, is
critical for survival. Cutaneous nerve endings sense these changes in the environment, conveying this information first to
the spinal cord via specialized sensory afferents that can discriminate between innocuous and noxious stimuli, the
latter by pain-sensing nociceptors. The sensations and the physiological effects of cold are distinct among somatosensory
modalities in that cold provides a pleasant, soothing sensation at mild temperatures, but is also agonizing as temperatures
decrease. The menthol receptor, TRPM8 is the principal cold sensor in mammalian sensory neurons. This and cells
expressing the ion channel are required for the sensations of both innocuous cool and noxious cold, heightened cold
sensitivity that results with injury or disease and, paradoxically, the ability of cooling to relieve chronic pain and itch.
These findings suggest that TRPM8 can centrally differentiate and propagate the distinct percepts of pleasant and
therapeutic cooling from painful and aggravating sensations of cold. But how does this lone channel and the cells
expressing it mediate these diverse physiological effects? We found that the glial cell-line derived neurotrophic
factor-like ligand artemin (ARTN) and its receptor GFRα3 are required for injury-induced, TRPM8-dependent cold pain,
the first evidence of a molecule that directly sensitizes cold in vivo. While the cellular and molecular transduction
mechanisms used by this signaling complex to induce cold pain have yet to be defined, these findings point to the
cohort of TRPM8+ afferents that express GFRa3 as cold nociceptors. We propose a model whereby injury of any
etiology leads to cold allodynia via peripheral release of ARTN that acts on GFRa3 receptors on TRPM8 cells to increase
their sensitivity to cold, transmitting this centrally via distinct neurocircuits. We propose to test this first by
determining the cellular basis for ARTN and GFRα3 mediated cold sensitization. Second, we have generated a novel
mouse genetic strategy to target the GFRa3+ and GFRa3- populations of TRPM8 afferents, allowing the lab to
differentially study these two cell types and determine their necessity for acute cold signaling, for pathological cold pain,
and for analgesic and anti-pruritic cooling in vivo. Lastly, it is critical to unbiasedly identify cold-tuned spinal cells to
determine how the pleasant and painful aspects of cold are processed. We have adapted an innovative genetic approach to
study cold-tuned spinal neurons molecularly, functionally, and behaviorally, allowing us to critically interrogate the
processing of peripheral cold signals at this first important site for conveying somatosensory and nociceptive information.
These studies will define the signal transduction pathways of cold and cold pain, providing not only insights into
somatosensory signaling and the mechanisms that bring about pain associated with this modality, but also potential
therapeutic interventions that use cold as a stimulus.

Public health relevance
Project Narrative This project will investigate the mechanisms that provide the nervous system with the ability to detect cold temperatures. The studies described will determine if these stimuli are transmitted via distinct neural circuits to mediate the range of behavioral and physiological responses to cold temperatures, providing not only insights into somatosensory signaling and the mechanisms that bring about pain associated with this modality, but also potential therapeutic interventions that use cold as a stimulus.